Core G - Imaging Biomarkers

SUMMARY - Imaging Biomarkers Core
Neuroimaging of amyloidosis (A), tauopathy (T), and neurodegeneration (N; collectively A/T/N) provide in vivo
evidence of the pathological hallmarks of Alzheimer’s disease (AD), affording earlier diagnosis of AD, qualitative
and quantitative measures for evaluation of intervention efficacy, and additional measurements of brain function
that may influence response to therapies targeting Alzheimer’s disease (AD) pathology. The Imaging Biomarkers
Core (a.k.a. Imaging Core) will advance and enhance innovative, inclusive efforts to translate discoveries from
bench to bedside, and to identify factors impacting the rich diversity of ADRD outcomes. The Imaging Core will
support imaging research with the goals of improving early diagnosis in diverse populations, discovering
neuroimaging measures associated with polygenic risk, identifying factors predictive of response to treatment,
and accelerating clinical trial research. The aims of the Core are to: 1) Create an environment conducive to using
neuroimaging data for multidisciplinary, inclusive research. This includes direct support for obtaining at least 24
A/T/N imaging sets per year using the SCAN protocol. The Core will prioritize diversity of the sample to increase
generalizability and examine health disparities in ADRD research. The Core will coordinate with related consortia
and investigator-initiated projects to support acquisition of the SCAN protocol beyond those directly acquired by
the Core. The Core will provide recommendations for acquisition with specific MRI sequences and PET tracers;
analytic pipelines; and expertise to support project design. 2) Provide broad, rapid sharing through interactions
with other Cores, across the institution, and with outside institutions. The Core will support rapid upload of data
to SCAN. The Core will facilitate informatics for banking and sharing processed neuroimaging data, help to route
imaging-characterized participants to best-matched studies and trials, and support a culture of open science to
encourage collaborative efforts across institutional boundaries. 3) Leverage imaging data to foster collaborations
and catalyze projects focused on imaging biomarkers related to polygenic factors, response to treatment, and
tools for discovery. The Core will emphasize polygenic risk in its activities and provide imaging data on genetically
characterized participants for polygenic analysis in relation to repose to treatment and discovery science. 4)
Enhance inclusive educational opportunities through neuroimaging training designed for richly diverse groups.
The Core will provide neuroimaging training to REC trainees and to investigators new to ADRD research, consult
with investigators to develop projects involving imaging, and will link clinical ADRD researchers to technical
expertise in imaging. These Core activities will support acquisition, analysis, informatics, and data sharing to
support the centrality of neuroimaging research for the efforts of the ADRC to accelerate understanding of
polygenic risk, response to treatment, and discovery science through imaging measures underlying diverse
expression of clinical symptoms.